Understanding Complex Genome Editing and RNA Biology in Oxytricha

Project Summary
The PI’s lab studies natural genome editing systems in microbial eukaryotes, bringing a strongly molecular and
mechanistic approach to understanding genome evolution and diversity. The surprisingly sophisticated
variations on DNA and RNA processing in microbial eukaryotes display a wide range of genome architectures
and genetic systems. Some pathways erode the notions of a gene (e.g. scrambled genes and RNA editing)
and even Mendelian inheritance, reminding us that a draft genome sequence can be a far cry from knowledge
of its products. Genome rearrangements occur in diverse organisms, and contribute to many human diseases,
especially cancer—a disease of the genome, but the extreme level of programmed DNA rearrangements
required for development in the ciliate Oxytricha make it an ideal model system to study genome remodeling
and the roles of RNA in orchestrating this process. The proposed research will expand the lab’s focus on the
molecular mechanisms and evolution of this remarkable natural phenomenon. Goals for the next five years
include understanding the roles of DNA N6-adenine methylation (6mA) during development and
rearrangement, and the interactions between small and long noncoding RNAs and their associated RNA-
binding proteins, together with the rearranging genome. Tools from molecular genetics, biochemistry, and
chromatin biology provide the platform for functional studies, while comparative genomics offers insight into
the evolutionary origins of scrambled genomes and complex genetic architectures, addressing the fundamental
questions of how programmed rearrangements are executed during development and how this process arose
during evolution.

Public health relevance
Project Narrative Genome rewiring events, through translocations, deletions, and even massive chromosomal rearrangements, contribute to genome instability associated with many human diseases, including a significant portion of cancers and inherited or spontaneous diseases. Furthermore, many classes of noncoding RNAs participate in genome remodeling pathways or the maintenance of genome integrity, and their loss or dysfunction can increase the frequency of genome rearrangements, resulting in either deletion of tumor-suppressing genes, formation of chimeric genes, or over-expression of genes that promote tumor stability. The extreme degree of natural genome editing events in Oxytricha make it unparalleled as a model system to study genome stability, and similar mechanisms that may contribute to genome instability and cancer in humans.